Neural determinants on meal size in invertebrate models of obesity

PROJECT SUMMARY
During eating animals modulate the size of meals by associating sensory cues with rewarding qualities of
food. This process is central to the control of food intake and is impaired in humans and animals exposed to
high fat and sugar diets. The neural mechanisms through which food associations 1) regulate meal size and 2)
are perturbed by this dietary environment, however, remain poorly understood. This lack of knowledge has
hindered progress in uncovering the underlying causes of obesity and, thus, in curbing the spread of metabolic
disease. Here we propose to use the D. melanogaster model to address the need for mechanistic studies on
the neural regulation and deregulation of meal size. A diet high in sugar promotes higher intake and obesity in
flies, but unlike vertebrate models, the neural circuits involved in food associations converge onto a single
brain region; further, transgenic tools to manipulate and visualize these circuits are publicly available, thanks to
decades of research and the connectome. Our long term goal is to use the unique advantages of the fly model
to uncover how food environments high in sugar and fat promote obesity and metabolic disease. Our central
hypothesis is that diet-driven changes in dopamine transmission underlie the increase in meal size observed in
animals fed high-calorie diets. This hypothesis is based on our published and unpublished data showing a
causal link between the dopaminergic processing of taste and nutrient qualities, the formation of food
associations, and intake. To test this idea we will use in vivo imaging of calcium and dopamine signals,
behavioral assays, metabolic measurements, and optogenetic manipulations of dopaminergic, associative
learning, and premotor circuits to define both the causes of impaired food associations (Aim 1) and their
consequences on meal size (Aim 2). The successful completion of the proposed studies will define how food
associations control intake and the extent through which diet-dependent alterations in DA signaling impact this
process; this will illuminate the neural mechanisms that regulate meal size and uncover how they are
deregulated by the food environment. Together, this will help advance our understanding of the causes of
obesity, which is key to the NIDDK mission of decreasing the burden and spread of metabolic disease.

Public health relevance
PROJECT NARRATIVE Consumption of foods high in sugar, salt, and fat is one of the underlying causes of obesity, a condition that affects more than 40% of Americans, promotes chronic disease, and lowers life expectancy. This dietary environment increases meal size and food intake to drive weight gain, but a mechanistic understanding of how this occurs is still elusive: the proposed experiments will use the fly model to address this question. Because the neurochemistry involved in meal size is conserved, these discoveries will advance our understanding of the role of the dietary environment in promoting obesity in ways that are directly related and translatable to mammals.